Develop positive allosteric modulators to enhance XCR1 signaling in cancer

Project Summary
Our long-term research goal is to develop positive and negative allosteric modulators targeting chemokine
receptors as a novel therapeutic approach for cancer treatment by modulating their activities. Towards this goal,
the current proposal will focus on XCR1, an important chemokine receptor expressed in conventional dendritic
cells subtype 1 (cDC1s). cDC1s are the most potent dendritic cells specialized in cross-presenting exogenous
antigens or cancer neoantigens on MHC class I molecules to CD8+ cytotoxic T lymphocytes (CTLs), serving as
a pivotal mechanism for initiating CTL responses against tumors in the tumor microenvironment (TME) and
playing a critical role in immune checkpoint blockade (ICB) therapy. A defining characteristic of both mouse and
human cDC1s is the expression of XCR1, which can respond to its chemokine ligand XCL1 produced by
activated CD8+ T cells and natural killer (NK) cells, mediating chemotaxis and activation of cDC1s within the
TME. Modulating the XCL1-XCR1 signaling may enhance cDC1 function and CTL responses in the TME.
Building on our recent progress obtaining purified XCR1 complexes and determining the first high-resolution
cryo-EM structure of the XCL1-XCR1-Gi complex, we propose utilizing DNA-encoded library (DEL) technology
to identify small-molecule XCR1 PAMs. We will take a new 'conformation selection' strategy to screen for XCR1
PAMs in a DEL. Extensive signaling assays will validate and characterize DEL screening hits, and we will obtain
cryo-EM structures of XCL1-XCR1 with the best candidates. Identifying XCR1 PAMs will provide a novel strategy
for enhancing anti-tumor immunity and establish a paradigm for developing PAMs for other chemokine receptors,
offering new therapeutic avenues by leveraging native immune mechanisms against tumor.

Public health relevance
Project Narrative Our study aims to identify the first small molecule positive allosteric modulators (PAMs) for XCR1, an important chemokine receptor that regulates the function of conventional dendritic cells subtype 1 (cDC1s) in the tumor microenvironment (TME). cDC1s are the most potent dendritic cells specialized in cross-presenting exogenous antigens or cancer neoantigens to CD8+ cytotoxic T lymphocytes (CTLs). Enhancing XCR1 activity with PAMs may promote cDC1 function and subsequent CTL responses in the TME, thereby representing a promising novel therapeutic strategy to boost antitumor immunity.